KY INBRE NOSI Supplement: Personalizing Disordered Eating Treatment Using Mobile Technology: Self-Guided, Personalized Treatment for Women

PROJECT SUMMARY/ABSTRACT
Three out of four (75%) women in the United States endorse problematic disordered eating
behaviors and cognitions, such as binge eating, purging, restriction, and/or body dissatisfaction.
Disordered eating is associated with a huge host of poor physical and mental health outcomes,
including heightened risk for cardiovascular disease, obesity, depression, anxiety, death by
suicide, poor quality of life, and can develop into clinical threshold eating disorders, which carry
one of the highest mortality rates of all psychiatric illnesses. Disordered eating disproportionally
impacts women with prevalence rates growing in the past two years. Despite the commonality of
disordered eating, there are few evidence-based treatments and prevention efforts that exist.
The treatments that do exist were developed and implemented in a standardized and ‘on
average’ manner. Despite the fact that there is extremely high heterogeneity in disordered
eating, both in terms of how disordered eating presents and in underlying causes, there are no
personalized treatments for disordered eating. Thus, it is unsurprising that treatments only work
for about 50% of women. The overarching goal of the current supplement is to refine and
implement a personalized, self-guided, digital intervention for women to address disordered
eating and promote overall health and well-being. The proposed research uses highly innovative
methods; data collected directly on the users’ smartphone is combined with state-of-the-art
idiographic modeling to deliver a digital, personalized, and self-guided intervention in women’s
everyday life. The specific aims of the current supplement are to (1) collect preliminary data on
the feasibility, acceptability, and user uptake of a personalized self-guided mobile intervention
for disordered eating in women (N=50) and (2) test the initial clinical efficacy of a personalized,
self-guided disordered eating digital intervention. The proposed research has clinical impact.
Ultimately, these data will lead directly to the creation and dissemination of an evidence-based
personalized, self-guided treatment for disordered eating. As digital interventions overcome
traditional barriers to accessing care, this research will create an easy-to-access deliverable that
can reach women who would traditionally be unable to access needed treatment. Additionally,
this research will provide training and educational experiences, consistent with the parent
proposal, for undergraduates, graduate students, post-doctoral fellows, and will help propel the
early career investigators toward additional independent funding. This proposal has high
potential to decrease a common and impairing problem for women and provide additional
training and resources to advance women in science.

Public health relevance
PROJECT NARRATIVE This project will collect data on the feasibility, acceptability, user uptake, and initial clinical efficacy of a personalized, digital, and self-guided intervention for disordered eating in women. The proposed research has significant public health relevance, as it will directly lead to a highly accessible and deployable personalized intervention that can be easily accessed and decrease the high societal burden, and physical and mental impairment associated with disordered eating, which affects 3 in 4 women. The proposed research is relevant to NIH’s strategic aim 3.3b, as it will lead to the creation of a personalized intervention consistent with NIH’s precision treatment initiative.